AOU WI Area of Interest 1: Community, Participant and Provider Engagement, Enrollment...

AoU-WI is a consortium of four healthcare and academic institutions. The primary goal of our consortium is to support the mission of AoU. AoU-WI will ensure the program is well positioned to study chronic diseases that impact children and adults, ensure NIH is at the forefront of biomedical research, and contribute to a national resource that fosters public confidence and varied perspectives built on rigorous scientific evidence.
The mission of the All of Us Research Program (AoURP) “is to accelerate health research and medical breakthroughs, enabling individualized prevention, treatment, and care for all of us.” The AoU-WI Consortium has shared this mission since the program’s inception. This mission is important since AoURP will be a research dataset with a unique capacity to conduct both basic and applied research to study both rare diseases and common chronic diseases that impact all Americans. AoURP will also allow researchers of all backgrounds the freedom to think differently yet conduct cutting edge, cost-effective, and reproducible research that provides transparency to increase public trust. To maintain AoURP’s mission and advance its goals, AoU-WI will leverage lessons learned from the last five years. In this application, we will describe how AoU-WI will not only maintain successful activities that has allowed our program to be leaders in engagement, enrollment, and retention, but also how we intend to innovate. AoU-WI will conduct outreach and engagement activities to promote enrollment across a spectrum of WI communities (Aim 1). We will also engage, enroll, and retain participants who reflect the rich makeup of the US (Aim 2). We will serve adults and children (Aim3) while ensuring participants have access to technology for study activities (Aim 4). Lastly, AoU-WI will engage and collaborate with health care providers serving all people to facilitate enrollment and retention (Aim5). By successfully achieving these aims, AoU-WI will contribute to an improved understanding of human diseases, promote cutting-edge research to ensure NIH is at the forefront of biomedical research, and build public confidence and trust in our nation’s research enterprise that values and encourages all perspectives.

Public health relevance
Data collected as part of AoURP is not about one single disease or even a class of diseases; it is about all diseases that can impact the health and wellbeing of all Americans. This resource will foster academic freedom, transparency, and be a trusted dataset for the public and scientists alike.